Research Project

RESEARCH PROJECT SUMMARY
Climate change poses risks to human health through direct and indirect stressors. On tropical islands, some of
the risks are accentuated. The population of the US Caribbean Territories, including Puerto Rico (PR) and the
US Virgin Islands (USVI), is especially vulnerable to multiple concurrent hazards heightened by global climate
change and the public health infrastructure that is weak, vulnerable, or absent due to historical and current
problematic policies and practices. PR and USVI are experiencing acute socioeconomic and health
consequences from extreme events including hurricanes Irma and Maria (2017) and the COVID-19 pandemic
(2020-2022). The proposed Caribbean Climate Change Adaptation, Cancer, and Health Disparities Research
Center (CCCARIB-CARES) will employ a multimethod approach to identify helpful strategies for addressing
these problems. CCCARIB-CARES will employ an epidemiological study to assess the risk of cancer in PR and
USVI in relation to climate vulnerabilities and socioenvironmental factors. It will include a cross-sectional study
to assess understanding of climate change and its effects on mobilizing pollution and affecting the quality of life
among cancer survivors. Furthermore, a qualitative study component will use key informants and focus groups
to determine the needs, priorities and capabilities of stakeholder groups, cancer patients, and residents living
in sites with low/high environmental disparities in relation to adaptation to climate-induced vulnerabilities. The
primary aims of the proposed project are to 1) Describe the risk of cancer in PR and USVI in relation to climate
stressors and socioenvironmental factors and 2) Conduct a community assessment of socioenvironmental
climate stressors and adaptation capacity among cancer survivors and residents experiencing environmental
disparities in PR and USVI. Information from the PR and USVI cancer registries will be used to assess cancer
incidence and mortality risk in the context of historical and current environmental data, in a framework that
evaluates social disparities. The study of the needs, priorities, and capabilities of stakeholder groups will
uncover weaknesses in the cancer control and healthcare continuum. This information will guide the
development of interventions and inform planning to respond and adapt to climate vulnerabilities in the
Caribbean region. The findings will be of relevance for government-based planning and intervention efforts,
including developing plans to mitigate the impacts of climate change locally, plans for disaster preparedness,
and improving the resilience of cancer control plans and infrastructure for these US territories. Lessons learned
will be of value to other US Territories Island states, and communities experiencing similar socio-environmental
climate vulnerability nationally.

Public health relevance
The US Caribbean is vulnerable to natural and environmental hazards and their impact on the cancer control continuum. The Caribbean Cancer Research Center on Environmental and Natural Hazards (CARIB-CARES) will increase capacity at PR and USVI to develop, support, and sustain research, preparedness, and adaptation capacities to help mitigate the impact of natural disasters and environmental pollution on the health of the population, within the context of the cancer prevention and control continuum.